Community Engagement Core

PROJECT SUMMARY (CEC)
The RCMI-Center for Health Disparities Research (RCHDR) Community Engagement Core (CEC) serves as
the nexus for the translation of novel research findings to reduce the incidence and prevalence of health
disparity-related diseases in the three-county area of Central Mississippi. Through an effective community
advisory board (CAB), JSU investigators and community stakeholders work together to facilitate community-
based participatory research and the translation of the resulting scientific knowledge to address the local health
disparity issues. The CEC overarching goal is to improve minority heath and reduce health disparities among
residents of Hinds, Madison, and Rankin counties in Central Mississippi, with a population of about half a
million of which 53% are underserved minorities. The CEC will achieve its goal through three specific aims
including the following: Specific Aim1. To establish long-term relationships with community based
organizations in order to address health disparity issues of concern to minority and underserved
communities. Approach: Identify key community partners and stakeholders. Build mutually beneficial
relationships with community-based organizations and local residents. Organize meetings and workshops with
advocacy groups and community-based organizations to identify, assess and prioritize health disparity issues
of concern. Involve community members in framing the research questions and research process for our Pilot
Project Program. Build upon and improve our strategic processes to sustain productive partnerships. Specific
Aim 2. To promote engagement in biomedical research and facilitate recruitment and retention of
community residents as study participants. Approach: Facilitate access of RCHDR investigators to field
sites. Utilize the RCHDR website to promote technology transfer and engage local communities in basic
biomedical, behavioral and/or clinical research aimed at promoting minority health and reducing health
disparities. Organize training workshops on health disparity issues of concern to minorities and underserved
communities in order to expand health knowledge and broaden community participation. Provide scientific
expertise and communicate the needs, significance and benefits of participating in translational research.
Specific Aim 3. To disseminate findings from research projects into community level practice and
prevention to improve community health, and reduce health disparities. Approach: Develop and
implement effective communication and outreach tools. Develop and largely distribute appropriate health
education materials to the community residents. Organize stakeholders’ seminars, workshops and conferences
to share the best practices in health disparity research and education. Further disseminate these best practices
and research findings though presentations and publications in scientific journals, social media
communications, and RCHDR website.

Public health relevance
PROJECT NARRATIVE (CEC) The RCMI Center Health Disparities Research (RCHDR) Community Engagement Core (CEC) plays a critical role in ensuring the bidirectional communication between investigators and the various advocacy groups and community organizations in order to implement cost-effective strategies to address critical health disparities issues in the tri-county area (Hinds, Madison and Rankin counties) surrounding the capital city of Jackson, Mississippi. It is a community-university partnership designed to improve minority health and reduce health disparities. The establishment of a Community Advisory Board (CAB) composed of community leaders, scientists, government officials and state agencies, faith-based organizations, and several grassroots health organizations creates a supportive framework to achieve this goal.